Targeting Tumor-Associated Macrophages via Hedgehog Inhibition to Enhance Immunotherapy in Non-Small Cell Lung Cancer

PROJECT SUMMARY
The prognosis for patients with metastatic non-small cell lung cancer (NSCLC) remains poor despite recent
progress in immune checkpoint blockade therapy. A better understanding of mechanisms for lung cancer
immune evasion within the tumor microenvironment (TME) will allow for the rationale development of more
effective and durable immunotherapeutic strategies for treating patients with lung cancer. Tumor-associated
macrophages (TAMs), a major component of the TME, generally display an anti-inflammatory phenotype and
can facilitate tumor growth by promoting angiogenesis, invasion, and metastasis, as well as immune evasion.
However, it remains largely undefined exactly how these TAMs regulate anti-tumor immune responses within
the TME. We have demonstrated preclinically that hedgehog signaling in TAMs induces intratumoral CD8 T cell
dysfunction in addition to regulating the recruitment of CD8 T cells to the TME, and that combining Hh inhibition
and PD-1 blockade has synergistic anti-tumor effects in vivo. We plan to test the hypothesis that Hh signaling in
TAMs suppresses CD8+ T cell recruitment resulting in pro-tumorigenic state within TME in patients with NSCLC
through the following specific aims: 1) Investigate the role of Hh inhibition with anti-PD-L1 therapy in patients
with non-small cell lung cancer (NSCLC), and 2) Study the impact of Hh inhibition on TAMs and changes within
the TME. To achieve these aims, we will conduct a multi-center phase Ib clinical trial of combination therapy with
vismodegib (hedgehog inhibitor) and atezolizumab (anti-PD-L1) in patients with metastatic NSCLC. The
objective of this project is to understand signals required for functional polarization of TAMs within the TME and
its contributions to immune cell dysregulations, cancer development, and progression, which may lead to the
development of novel therapy for patients with NSCLC.

Public health relevance
PROJECT NARRATIVE The prognosis for patients with metastatic non-small cell lung cancer (NSCLC) remains poor despite recent progress in immune checkpoint blockade therapy, and there is a need to develop more effective and durable immunotherapeutic strategies for treating lung cancer. Tumor-associated macrophages play an important role in promoting tumor growth, angiogenesis, metastasis, and immune evasion; however, how tumor-associated macrophages regulate anti-tumor immunity within the tumor microenvironment in lung cancer remains largely unknown. This proposal will study the role of tumor-associated macrophages in inducing intratumoral T cell dysfunction and test a novel strategy in a clinical trial targeting tumor-associated macrophages for treating patients with NSCLC.